The Impact of Menthol Flavoring on Switching in Adult Menthol Smokers

PROJECT SUMMARY/ABSTRACT
Tobacco control policies targeting menthol flavoring could have a significant impact on public health. When
added to cigarettes, menthol increases addictive potential and dependence, leads to greater inhalation of
tobacco toxicants, and decreases the likelihood of cessation. These effects are particularly felt in the African
American (AA) community where targeted marketing has resulted in ≈85% of AA versus ≈20% of White
smokers using menthol cigarettes. The FDA’s decision to advance the rulemaking process to ban menthol
cigarettes is an important step toward closing the gap in tobacco-related disease and death disproportionately
experienced by AA smokers. The agency’s regulatory action stopped short of including menthol-flavored e-
cigarettes (ECs) and debate continues about whether more comprehensive enforcement priorities inclusive of
menthol flavored e-liquids should be enacted. While a ban on menthol flavored EC may reduce youth and
young adult initiation, it may also discourage adult menthol smokers to switch from tobacco cigarettes to EC.
This could slow harm reduction and result in a negative public health impact that would be concentrated in
racial/ethnic minority communities already disproportionately burdened by tobacco. FDA has identified the
impact of EC flavoring on smoking patterns as a research priority area, and there is an urgent need for studies
that examine possible unintended consequences of regulatory actions on tobacco-related health disparities.
Our recently completed randomized clinical trial (RCT) provided menthol EC or tobacco EC to adult smokers.
Among menthol smokers, we found equivalent rates of switching from tobacco cigarettes to EC, tobacco harm
reduction, EC product use, and acceptability between those who used tobacco EC versus menthol EC,
although the study was limited by a small sample size and was not prospectively designed for these
comparisons. These data are consistent with observational studies that have found that nicotine – not flavor –
drive use in adult EC users and provide strong preliminary evidence to support restrictions on menthol flavored
EC given potential benefit to youth and lack of evidence of harm to adult smokers. However, a prospectively
designed and fully powered RCT is needed to empirically answer this question. The objective of this application
is to provide much needed data to the FDA to guide regulatory action on EC flavoring. Menthol smokers (n=800),
stratified by race and gender, who are interested in switching to EC, will be randomized 1:1 into a 12-week open
label, non-inferiority RCT comparing menthol EC versus tobacco EC. Follow-up will continue through week 26.
The central hypothesis is that tobacco EC are not inferior to menthol EC at facilitating a switch to EC in menthol
cigarette smokers. We further hypothesize no difference in tobacco harm reduction, EC product use, or
acceptability between participants randomized to tobacco EC versus menthol EC. The study will provide critical
data to the FDA to inform regulatory action for menthol EC that could slow youth initiation with no resulting
negative impact on switching in adult combustible cigarette smokers.

Public health relevance
PUBLIC HEALTH RELEVANCE To our knowledge, this is the first study prospectively designed to directly compare effectiveness and acceptability of menthol EC versus tobacco EC in menthol smokers transitioning to EC. We expect that both products will be acceptable and result in high rates of switching and improvements in tobacco-related health effects. Impact on the field will be significant. The study will provide critical data to the FDA to support restrictions on menthol EC that could slow youth and young adult initiation with no resulting negative impact on switching in adult combustible cigarette smokers transitioning to EC and no unintended consequences in a priority population of predominately African American and Latinx smokers.